Discovery, Regulation and Function of the PI 3-Kinase and AKT Pathway in Cancer

The phosphoinositide 3-kinase (PI3K) pathway is one of the most frequently deregulated signaling
cascades in human cancers, regulating virtually all aspects of tumorigenesis in humans, including initiation,
progression and metastatic dissemination. The serine/threonine protein kinase AKT transduces PI3K signals to
a plethora of cellular responses that are associated with malignancy, including cell proliferation and growth,
survival, cell motility and metabolism. In spite of extensive efforts aimed at decoding the function of PI3K/AKT
signaling in cancer, and a multitude of small molecule inhibitors developed and aimed at interrupting one or
more enzymes in this pathway, robust therapeutic responses to PI3K or AKT inhibition have to date remained
elusive. There is therefore an urgent need to identify previously unappreciated vulnerabilities associated with
PI3K/AKT pathway addiction. Over the past two decades, our laboratory has been at the forefront of
discoveries on the regulation of AKT downstream of PI3K, as well as identifying mechanisms by which AKT
mediates signal relay to cellular phenotypes associated with malignancy. This application builds on our
collective experience at deciphering the contribution of PI3K and AKT in cancer with emphasis at discovering,
identifying and characterizing vulnerabilities associated with PI3K/AKT pathway addiction. In the proposed
projects, we will focus our vision in three major areas of work: 1) targets of PI3K/AKT defined by genetic
approaches: we will define targets of AKT that modulate cellular phenotypes using defined CRISPR screens
that combine gene targeting with mass spectrometry and functional validation. We will also use new genetic
mouse models that recapitulate AKT hyperactivation and evaluate sensitivity to targeted therapies; 2) novel
chemical probes and screens targeting AKT: we have generated the first in-class degrader or PROTAC that
potently and specifically degrades AKT, and out-performs all current AKT inhibitors. We will use this novel
probe to target the AKT pathway in cancer. We will perform synthetic lethal CRISPR screens to uncover
targets that when combined with PI3K and AKT inhibitors transform cytostatic responses to cytotoxic ones; 3)
regulation of protein glycosylation by PI3K/AKT: we have uncovered an entirely new mechanism by which
growth factor and oncogenic signaling through PI3K/AKT/mTOR modulates the N-glycosylation pathway,
necessary for proper protein folding in the endoplasmic reticulum (ER). Deregulation of this mechanism leads
to induction of ER stress. This is the first identification linking oncogene addition to anabolic carbohydrate
metabolism, which we will explore with functional glycomics. The proposed studies not only build on our
expertise, they also emphasize the urgent need to obtain detailed new insights into the pleiotropic mechanisms
that govern PI3K and AKT signaling in cancer. Our findings will provide an integrated, mechanistic
understanding of how oncogenic signaling interfaces with cellular reprogramming and expose cancer-specific
vulnerabilities that would ultimately lead to the development of new therapeutic opportunities for cancer.

Public health relevance
Project Narrative The PI3K (phosphoinositide 3-kinase)/AKT signaling pathway is one of the most frequently deregulated signaling nodes in virtually all human solid and hematological malignancies. The overall goal of this 7 year application is to dissect the regulation and function of PI3K and AKT proteins in the context of modulating reprogramming of metabolic pathways and identifying downstream mechanisms of PI3K and AKT that lead to tumor initiation and progression. We propose that new findings emerging from this project may lead to new therapeutic opportunities for effectively treating those cancers that harbor PI3K pathway lesions.